Appalachian Gerontology Experiences - Advancing Diversity in Aging Research

Appalachian Gerontology Experiences: Advancing Diversity in Aging Research
(AGE-ADAR)
Specific Aims
Appalachia is a predominantly rural area in which 25 million Americans reside. The region
includes all of West Virginia and portions of 12 other states. Relative to the rest of the United
States, West Virginian Appalachia is rugged and mountainous, which creates geographic
barriers to medical and psychosocial services. Residents of the region also live with lower
annual incomes, higher poverty, higher unemployment, and higher morbidity and mortality rates
than other areas of the nation (Appalachian Regional Commission, 2017). Thus, it is a region
marked by significant health disparities.
Health disparities are more pronounced in the rural areas of Appalachia and are a complex
result of health behaviors, personal resources, and macro-environmental influences. Although
rural-dwelling adults have many of the same needs as adults aging in other environments, there
are unique issues presented by a rural context. Thus, as we have argued elsewhere, aging is
harder in rural areas (Hash, Jurkowski, & Krout, 2015). For many Appalachian residents, there
is a strong sense of place-identity, with an historical mistrust of “outsiders” who often lack the
cultural competence to address the nuances and complexities of Appalachian culture. Thus,
what is needed is a cadre of health professionals and researchers who are well-versed in
the science of aging, the science of health disparities, and the culture of Appalachia. To that
end, we propose a highly-scaffolded education experience to increase interest in and diversity
among researchers in aging and health disparities in Appalachia.
The overarching goals of this project align with the goals of the NIA to increase interest in
reducing health disparities and increasing the representation of historically underrepresented
scholars in the fields of aging and health disparities research. To accomplish these goals, the
proposed educational program would provide: focused educational content on research
methods, aging, health disparities, Appalachia and other rural areas. The program would
include structured, hands-on research experiences and mentored research experiences. We
would nurture an appreciation for applied/translational research and community-based
dissemination, thus increasing the health literacy and scientific literacy in the region.
Together, these experiences would prepare scholars to infuse a healthy aging approach to
their work. Specifically, the proposed program would:
1. provide culturally- and regionally-relevant educational content on aging, health
disparities, Appalachia and other rural areas;
2. provide an intensive introduction to research methods, including completion of at least
one structured group research experience focused on health disparities and a second
mentored, health-related aging research experience with a faculty sponsor in the
student's home discipline;
3. create and reinforce an identity of being an aging and health disparities researcher who
will contribute to the research workforce in aging;
4. coach students on scientific writing and professional development; and
5. increase scientific and health literacy in the community through broad dissemination of
research findings.

Public health relevance
Diversity among scientists increases our ability to solve the problems facing society. The proposed educational program seeks to increase the diversity of the workforce in aging and health disparities as a means to reduce such health disparities. Focusing on students who are typically underrepresented in the MSTEM fields, the Appalachia Gerontology Experiences (AGE) Scholars Program would provide content knowledge and hands-on experiences in aging and health disparities research.